Cellular Pathophysiology of Neuronal Na/K-ATPase Dysfunction

SUMMARY
Heterozygous loss-of-function mutations in ATP1A3, the gene encoding the catalytic (α3) subunit of the neuronal
Na/K-ATPase, are associated with a spectrum of neurodevelopmental syndromes including the prototypical
disorder Alternating Hemiplegia of Childhood (AHC), which has no effective therapy. These conditions are
associated with acute attacks of transient weakness and dystonia, and poor long term outcome with delayed
neurodevelopment and brain atrophy believed secondary to chronic neuron loss. Although rare, ATP1A3
mutations evoke neurological dysfunction shared by common disorders such as epilepsy and migraine. While
much has been learned about the genetic basis of these disorders, the cellular consequences of ATP1A3
dysfunction in human neurons and fundamental pathophysiological mechanisms are poorly understood. We
have modeled the cellular effects of ATP1A3 mutations using neurons differentiated from patient-specific induced
pluripotent stem cells (iPSCs). We propose to exploit this model to determine cellular pathophysiological
mechanisms associated with impaired Na/K pump activity and the resulting altered ion homeostasis that explain
both short term (hemiplegia, dystonia) and long term (developmental delay, chronic neuron loss) manifestation
of ATP1A3 dysfunction. In Aim 1, we will test the hypothesis that direct measurement of neuronal pump current
can distinguish between haploinsufficiency and dominant-negative mechanisms, and determine if impaired pump
activity can be rescued with a viral ATP1A3 transgene. In Aim 2, we will test the hypothesis that a blunted
transmembrane K+ concentration gradient causes a depolarized neuronal resting membrane potential as a
consequence of lower than normal driving force mediating outward K+ leak current, which impacts neuronal
excitability. We will test this hypothesis by determining if potentiating K+ leak channel activity pharmacologically
or genetically in ATP1A3 mutant neurons will compensate for the blunted intracellular to extracellular K+ driving
force, normalize the resting potential and prevent depolarization block. Separate experiments will investigate
susceptibility to and recovery from depolarization block between mutant and non-mutant neurons, and correlate
these findings with intracellular Na+ dynamics. In Aim 3, we will investigate potential cellular pathophysiological
mechanisms responsible for the long-term manifestations of ATP1A3. We will test the hypothesis that ATP1A3
mutant neurons exhibit a delayed GABA switch and this can be corrected by inhibition or knockdown of the
Na/K/2Cl cotransporter (NKCC1). Finally, we will test hypothesis that impaired Na/K-ATPase activity renders
neurons susceptible to intracellular Na+ overload, which can trigger cytosolic Ca2+ overload and cytotoxicity.
Collectively, this work will reveal important aspects of short- and long-term neuronal pathogenesis associated
with ATP1A3 dysfunction, and promote a mechanistically driven approach to finding new therapeutic strategies.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to determine the cellular mechanisms responsible for neurodevelopmental disorders associated with mutations in the gene, ATP1A3. This gene encodes a protein involved with maintaining ion gradients in neurons, which are required for normal neuron function. ATP1A3 mutations cause severe childhood-onset neurological diseases with inadequate treatment options, and our work will help inform new therapeutic strategies.